Clinical Core

PROJECT SUMMARY/ABSTRACT:
A key foundational component of this P30 application is the Personalized Clinical Core, which will be the
primary source of human cells, tissues, biofluids [e.g.: sputum, bronchoalveolar lavage fluid (BALF), sweat,
serum] and translational research expertise. The Personalized Clinical Core builds directly on current
clinical research strengths and infrastructure at CCHMC, including the CFF-TDN program, the CF-RDP
program, investigator-initiated research, and institutional commitments to CF translational research. The
Personalized Clinical Core will expand these capabilities in critical ways, focusing exclusively on obtaining
patient-derived biospecimens accompanied by clinical correlates, and providing full clinical research
capabilities to operationalize novel translational research projects. The Personalized Clinical Core will
coordinate the procurement, expansion, banking, and distribution of human specimens, and provide
translational researchers with appropriate clinical research support to execute and interpret clinical
investigation. The vision of this P30 Core is to enhance the CF-focused research on campus by provision of
well-characterized, high quality and human-only samples from CF patients and appropriate non-
CF controls. Centralizing these capabilities through the Personalized Clinical Core structure will help to
drive research efficiencies and standardization. In addition, the samples obtained and processed through
the Personalized Clinical Core will be available for direct use by CF researchers, and for projects utilizing
the Personalized Model Systems Core and the Atlas of the CF Respiratory Epithelial Cells Core.